New Mexico Health Information Collaborative

[unreadable] DESCRIPTION (provided by the applicant): The overall goal of the New Mexico Health Information Collaborative (NMHIC) is to develop a community-wide (and eventually statewide) health information exchange that will improve care coordination and chronic disease outcomes, and reduce unnecessary costs of care. Recognizing that dramatic changes in health care will not occur with adopting IT alone, an additional goal is to create a culture of personal responsibility for health among the stakeholders (employees, employers, providers, and health systems and plans) and in particular among consumers. This will be accomplished through four specific aims: (1) to develop the organizational infrastructure; (2) to develop community-wide disease-management prototypes (diabetes, pediatric asthma, depression, and low back pain) that utilize eHealth strategies to improve care and reduce costs; (3) to establish a rural pilot which will serve as a model for other rural areas; and (4) to evaluate the development, implementation, and outcomes of the health information collaborative. The Collaborative, initially driven by several business leaders with concerns over unrelenting escalation in health care costs, has brought together businesses, health systems, and plans, philanthropic organizations, government, schools, and the University of New Mexico to develop a health information exchange that enables providers, employees/patients, and employers to work in concert to improve the health of each individual diagnosed with a chronic disease. Through Internet access to claims data that has been transformed into usable health information, providers and patients/employees will be able to have access to comprehensive and relevant clinical data no matter where the patient received care. Community disease-management guidelines will facilitate consistency of care among providers and assist patients in developing self-management goals. Employers will receive aggregate reports on the health of their workforce, enabling them to develop and measure the effectiveness of worksite wellness programs. Two strengths of this proposal will contribute to its success: broad-based community collaboration and leadership, and uniqueness and innovation of the concept. A third strength is that the project will be led by Lovelace Clinic Foundation, an independent, not-for-profit health services research organization, which has extensive experience in project management, disease management, dissemination of best practices, IT planning and development, and outcome measurement. Following the startup phase of this project, NMHIC will be transferred to an independent, not-for-profit organization governed by community stakeholders. [unreadable] [unreadable]